Self-Management Interventions: Considering Needs and Preferences of Dementia Caregivers

Project Summary/Abstract:
With every passing minute, a family member begins a “caregiving career” consisting of the provision of
informal care for an elder with Alzheimer's disease or other dementia. During the caregiving career, these
family members (i.e., carers) progress through three distinct phases, from primary caregiver in the home, to
care partner when the care recipient requires long-term placement, to caretaker after their loved one has
passed away. As family carers experience transitions from caregiver to care partner to caretaker, they face
changes in their care recipient's needs, behaviors, and symptoms that may adversely affect their own health.
Although preliminary clinical trials show Heart Rate Variability Biofeedback (BF) and Resourcefulness Training
(RT) are two beneficial health self-management interventions for dementia caregivers, the effects of delivering
these interventions according to carer need or preference have not been examined. This randomized
controlled trial will therefore evaluate the effects of health self-management interventions (BF or RT) delivered
according to carer need or preference compared with an attention control condition on caregiving responses
(perceived stress, depressive cognitions, and negative emotions) and health outcomes (health risks and
physical and mental health) over time. Carers will be randomized to: 1) an attention control (i.e., diversional
activity) group, 2) self-management intervention based on need (SM-need), or 3) self-management intervention
of their preference (SM-preference). SM-need will be determined by the lowest cut score on validated
measures of heart rate variability (for BF) and resourcefulness (for RT). SM-preference allows the carer to
choose between BF and RT. The study aims to: 1) examine the effects of a health self-management
intervention (BF or RT) delivered by need or preference in family carers of persons with dementia on
caregiving responses and health outcomes over time; and 2) determine whether differences exist among
caregivers, care partners, and caretakers in carer responses and health outcomes over time. Family carers will
be assessed at baseline (T1), 6 months (T2), and 12 months (T3) post-intervention. Interventions will occur
between T1 and T2 data collections. Repeated measures bivariate and multivariate analyses will control for
months in carer role, dementia symptom severity, and caregiving demands while addressing the study aims.
The study findings will generate new scientific knowledge about the effectiveness of novel, easy-to-use,
independently performed interventions that can be self-tailored to promote the health of carers of persons with
dementia throughout their caregiving career. Once established, these health self-management interventions
can be tailored to match the needs and preferences of other comparably distressed family caregivers of
persons with other chronic mental or physical conditions.

Public health relevance
Project Narrative: Every minute, a family member begins a “caregiving career” consisting of the provision of informal care for an elder with Alzheimer's disease or other dementia. During this career, which is marked by transitions from caregiver in the home to care partners with a facility to caretaker following bereavement, declines in the carer's mental and physical health may be prevented through previously unexamined health self-managements interventions that are tailored for them according to their needs or preferences. Our findings will generate new scientific knowledge about the effectiveness of novel, easy to use, independently performed interventions that can be individualized and self-tailored to promote the health of other comparably distressed family caregivers.